STUDYING SINGLE NEURON COMPUTATIONS WITHIN BRAIN-WIDE CIRCUITS

PROJECT SUMMARY/ABSTRACT
All our sensations, decisions, and actions are mediated by signals flowing through networks of neurons, the
fundamental information-processing units of the brain. Each neuron receives thousands of inputs from other
neurons at synapses and converts particular patterns of inputs into output (action potentials). Understanding the
operations that neurons can perform will help reveal the algorithms that the brain utilizes to produce behavior. A
rich body of theoretical work has put forward several models of neural computation of varying complexity. Some
propose that spatially clustered inputs are more effective at driving output whereas other models suggest that
diffuse input is better. It is still unclear which models, if any, accurately describe single neuron computation in
vivo and during behavior. The study of single neuron computation requires the simultaneous measurement of
many inputs to, and the output from, a neuron in vivo, which has not yet been possible. In my research, I will
leverage novel imaging technologies to overcome current limitations and measure the input and output signals
of individual cortical neurons. I hypothesize that action potential generation in vivo is more likely after a neuron
receives clustered synaptic input. I will address this hypothesis through the following Specific Aims:
Aim 1: Characterize the spatiotemporal relationships between synaptic input patterns and action potentials.
Aim 2: Investigate how inputs change when the brain drives activity in a specific neuron.
Aim 3: Determine whether hierarchical nonlinearities are needed to model a neuron’s computation.
This project will result in new models of the neuron that better represent the range of computations performed in
vivo. Given that neuropsychiatric diseases, such as schizophrenia, autism spectrum disorder, and bipolar
disorder, have been hypothesized to affect proteins that dictate a neuron’s computational properties, a
comprehensive understanding of neural computation would allow for mechanistic explanations of how such
diseases affect patients’ cognitive capabilities.

Public health relevance
PROJECT NARRATIVE The ability of neurons to process information underlies every one of our sensations, decisions, and actions, but the specific operations neurons can compute in vivo are unknown. Leveraging cutting-edge technologies, this study will characterize and model the diverse set of computations that individual neurons in living organisms perform. As genes coding for proteins involved in the computational properties of neurons have been implicated in several neurological diseases, including autism spectrum disorder and schizophrenia, deeper insights into how neurons compute will revolutionize our understanding of how these diseases affect cognitive function in patients.